Differential regulation of plant innate immunity

Differential regulation of plant innate immunity
Project Summary
The innate immune system detects pathogen-derived molecules to prevent infections via specialized immune
receptors. The immune receptors include cell surface-resident pattern recognition receptors (PRRs), such as
Toll-like receptors (TLRs) in mammals and receptor-like kinases (RLKs) in plants, and intracellular NOD-like
receptors (NLRs), such as plant nucleotide-binding domain leucine-rich repeat proteins. Plant plasma
membrane-localized RLKs function as PRRs that sense pathogen-associated molecular patterns (PAMPs) and
collectively contribute to host immunity against a broad-spectrum of pathogens. Plant intracellular NLRs detect
pathogen specific effector proteins that are translocated into host cells and trigger pathogen-specific immunity,
often accompanied with programmed cell death. The genetic tractability of plants made it possible to identify
many plant PRR and NLR immune receptors. However, how the signaling networks underlying PRR- and NLR-
mediated immunity are interconnected remains largely unknown. The PI’s laboratory has developed a series of
sensitive and high-throughput genetic screens to reveal the complex activation and signaling mechanisms in
plant PRR- and NLR-mediated immunity. The screens point to an unexpected role of a group of RLKs with an
extracellular malectin-like domain in plant immunity. The ample preliminary evidence supports a tantalizing
hypothesis that specific malectin-like RLKs regulate two-tiered plant immunity and cell death by differential
modulation of PRR and NLR immune receptor complexes. Specifically, this project seeks to elucidate: how
malectin-like RLKs, LET1 and LET2, inversely regulate PRR and NLR complex formation and activation; how
LET1/2 are modulated by glycosylphosphatidylinositol (GPI)-anchored LLG1 as an adaptor and secreted peptide
RALF9 as a ligand; and how NLR protein SUMM2 stability is inversely regulated by two distinct E3 ubiquitin
ligases. By elucidating cell surface-resident malectin-like RLK module as a molecular link of PRR and NLR
immune receptors, the project has the potential to change the dogma of the interconnection of PRR and NLR-
mediated immunity, which was previously thought to function independently at the receptor level and only
converge in downstream signaling events.
Plant PRR- and NLR-mediated immunity is analogous to mammalian TLR- and NLR-mediated innate immunity
respectively. Uniquely, the enriched genetic and genomic resources, including the collection of whole-genome
knockout lines, as well as the well-established cellular and biochemical assays present Arabidopsis as a tractable
model system to understand the host immune mechanism at the whole organismal and physiological level. Thus,
the impacts of the project will reach beyond plant biology and provide complementary views to the general
understanding of innate immune signaling.

Public health relevance
Project Narrative Recent advance on the molecular architecture of nonself recognition has revealed remarkable conservation in the mechanisms of microbial perception and innate immune signaling from plants to worms, insects and mammals. Our study on elucidating the signaling networks orchestrating plant immune responses will not only contribute to the current efforts of understanding molecular basis of plant immunity, but also shed light on the evolutionarily convergent mechanisms in cellular signaling of animal innate immunity. We believe that our study is relevant to the mission of NIH and is fundamental for basic medical research.